SWG 8: Adolescent Health

Abstract
Adolescents, both in the US and globally, are a key population affected by HIV, and novel research strategies
are needed to prevent, treat, and potentially cure HIV in this vulnerable group. The primary purpose of the
Adolescent Health Scientific Working Group (SWG) is to catalyze innovative research by bringing together
investigators with interest and experience in addressing the unique issues facing adolescents in HIV treatment,
cure, and prevention, including development of biomedical HIV prevention approaches, optimized models for
care and treatment, and relevant behavioral and laboratory science. First, we will initiate a monthly research
work-in-progress group, to create a peer network and collaborative space for investigation and discovery
pertaining to adolescent health and HIV, which will enable scientific mentoring and access to CFAR resources,
including the Behavioral Science, Implementation Science, and Developmental Cores, and eHealth SWG. This
will efficiently facilitate investigators to develop novel research programs and collaborations pertaining to
adolescent health and to access trainee support and funds (Aim 1). Second, by holding skill-building
workshops, we will fill gaps in members' knowledge of current methods for adolescent HIV research, and link
investigators to timely and innovative approaches to conducting research with adolescents. Our
multidisciplinary workshops will incorporate topics related to adolescent medicine, behavioral science,
implementation science, and laboratory methods, and will build institutional expertise in novel methodological
approaches to HIV research involving adolescents (Aim 2). Third, we will stimulate institutional interest and
enthusiasm for the topic of adolescent health and HIV by hosting global leaders in this field as visiting scholars
in Seattle (Aim 3). We will disseminate invitations to participate in all activities to CFAR consortium partners, as
well as local partners such as the Bill and Melinda Gates Foundation and to our international partners, which
will enable circulation of ideas and approaches on defeating HIV among adolescents, creating relevant
synergies for both global and domestic HIV research.
These comprehensive activities will enable our CFAR members to develop robust research in adolescent
HIV prevention and treatment, with cross-disciplinary approaches and multiple institutional collaborations. This
SWG will advance HIV science by highlighting research strategies and topics specific to adolescents that are
currently under development by HIV researchers and others; SWG researchers will benefit from multiple
venues to share experiences and learn from one another. By designing a SWG that focuses on adolescent
health, we will ensure that CFAR researchers have opportunities to establish strong collaborations to work with
this vulnerable population and promote the adoption of an adolescent-focused research agenda. Our unique
strengths in both domestic and global HIV research will allow us to connect adolescent research in both arenas
to cross-pollinate ideas, strategies and best practices.